Impacts of nicotinamide riboside on functional capacity and muscle physiology in older Veterans

Impacts of nicotinamide riboside on functional capacity and muscle physiology in older veterans
Frailty is increasingly seen within the aging
population and is driven largely by musculoskeletal declines.
Nearly 9 million veterans are now 65 years of age or older
with impairments in functional capacity, reduction in quality
of life, and an increase in the use of health care services and
associated costs. An estimated 45-50% of those over the age of
85 are frail, which could represent well over 1 million
veterans. Aging, which significantly contributes to frailty, is
highly correlated with reduced levels of nicotinamide
adenine dinucleotide (NAD+), an essential mediator in
mitochondrial function. Restoration of cellular NAD+ levels is
gaining support as a therapeutic strategy to maintain and
even enhance functional capacity during aging. Nicotinamide
riboside (NR) - an NAD+ precursor - enhances physical
activity and mitochondrial health in mice. Furthermore, NR
was recently shown to be safe in human clinical trials for
boosting NAD+, yet the benefits for human physical performance and muscle physiology are
unknown. Therefore, the goal of this project is to establish a double-blind randomized control trial to
assess the impacts of NR on functional capacity, muscle function and structure, and mRNA signaling in
healthy older adults. Towards this goal, this study will investigate healthy older individuals between
the ages of 65-85 who will receive NR or a placebo for a period of 3 months. Participants will be tested
for frailty, gait speed, and muscle strength at each time point. Additionally, muscle biopsies and serum
will be collected to assess changes in muscle fiber histology, mitochondrial biomass and activity, and
mRNA profiles. This project will provide greater insight into NR supplementation as a therapeutic
strategy to stave off frailty and maintain resilience during aging.
HIIT enhances physical performance
and reduces frailty during aging.

Public health relevance
Frailty is an age-associated clinical condition of poor physiological reserve that increases risks for falls, hospitalization and mortality. Nicotinamide adenine dinucleotide (NAD) is a critical co-factor across multiple cellular processes, for which the decline with aging is linked to physical performance decline in animals. Human trials have demonstrated that nicotinamide riboside (NR) is safe and effectively increases NAD+ levels, and NR improves treadmill performance in animal trials. Here we propose a double-blind randomized control trial to assess the impacts of NR supplementation on muscle function and physiology. We anticipate our research findings will support the use of this nutritional augmentation to improve the health of our veterans during aging.